TURNing RanBP9 on NSCLC

Project Summary
Remarkable advancements have been recently achieved in the treatment of Non-Small Cell Lung
Cancer (NSCLC). Targeted- and immune-therapy have produced spectacular patient remissions
unimaginable only 5 years ago for this disease that is the number one cause of cancer related deaths in
the developed world. Unfortunately, most patients do not achieve a durable response and are not cured.
Therefore, there is still an urgent need for new therapeutic targets and strategies to treat this devastating
malignancy.
The protein RanBP9 could be an attractive target for the treatment of NSCLC. RanBP9 protects NSCLC cells
from stress induced by DNA damaging agents such as platinum based-drugs. The higher its levels, the worse
the NSCLC patient response to platinum-based drugs. This scaffold protein is significantly over-expressed
in NSCLC cells when compared to the normal counterpart, which is expected on the basis of its anti-
stress protective functions. Thus, a therapeutic window might be open to target RanBP9 without damaging
normal cells. On the other hand, like numerous other potential targets for cancer therapy, RanBP9 is
widely expressed. Relatively high expression of RanBP9 is found in the brain and in the gonads, for
example. Therefore, before taking the idea of inactivating RanBP9 to the clinics, careful work needs to be
done to better understand how RanBP9 protects cells from DNA damage. Other than in cancer cells, it is
particularly important to establish how this proteins works also in tumor associated macrophages (TAMs),
which have been shown to promote tumorigenesis and resistance to therapy. To achieve these goals,
whole organism modeling is necessary.
This proposal seeks to study by advanced proteomics the changes of the molecular interactions that
RanBP9 shows in both normal and cancer cells when treated with cisplatin. To distinguish the interactions of
RanBP9 in cancer cells from those in the rest of the tumor microenvironment, we will use a new mouse line
called RanBP9-TURN in which RanBP9-HA is turned off and RanBP9-V5 is turned on in cells where Cre is
active.
In the first specific aim (Aim 1) of this proposal, we will study the interactions of RanBP9 in type II
pneumocytes and in alveolar macrophages in a mouse model in which RanBP9 tag is switched from HA to
V5 upon Cre-recombination. This will establish the changes of the RanBP9-interactome following treatment
with cisplatin in normal alveolar type II cells and alveolar macrophages. In the second aim (Aim 2), we will
study the dynamics of RanBP9 protein interactions in NSCLC cells and TAMs upon DNA damage. This will
reveal the RanBP9-interactome changes in cancer cells and TAMs following DNA damage by cisplatin.
When accomplished, this study will add support to the pursue of mechanistically-designed therapies to
treat NSCLC based on the targeting of RanBP9. It will also open new lines of investigation into unknown
mechanisms of the cellular response to DNA damage. Finally, the RanBP9-TURN will be a prototype in the
field of mouse modeling for investigations into the tumor microenvironment.

Public health relevance
Project narrative This project studies the role of a protein named RanBP9 in protecting lung cancer cells from drugs commonly used in the clinics. The proposed work is based of an innovative murine model of human lung cancer in which cancer cells will express RanBP9 with a different biochemical identifier compared to other cells within the tumor microenvironment. When accomplished, this project will reveal unknown interactions of RanBP9 with other proteins, which could be useful for mechanism-designed therapy of lung cancer.